Development of Oral Immunotherapy against Clostridioides difficile Transmission

Abstract
Clostridioides difficile is a gram-positive bacterial pathogen responsible for severe gastrointestinal infections,
often leading to life-threatening complications, particularly in healthcare settings. C. difficile produces
environment resistant spores that are the major source of transmission. Both symptomatic patients and
asymptomatic carriers in hospitals and nursery homes serve as reservoirs for C. difficile spores. Current
preventive strategies for C. difficile infections (CDI) are limited and there is no treatment available to reduce
spore production and prevent the spread of this pathogen.
We have recently identified a panel of single-domain variable fragments of heavy-chain only antibodies (VHHs)
against conserved Cwp84, a surface-associated cysteine protease important for bacterial colonization and
sporulation. We found that a VHH heterodimer could inhibit the sporulation in vitro. Most importantly, oral
administration of mice with the engineered yeast secreting the bi-specific antibody during the CDI not only
reduced disease severity, but also significantly diminished spore shedding. In this project, we propose to
develop a novel probiotic yeast-based immunotherapy that utilizes the engineered probiotic yeast as a vehicle
to deliver the neutralizing antibodies against Cwp84 in gut to reduce C. difficile colonization and spores
shedding subsequently preventing transmission. This study will further screen for lead bi-specific VHH
antibodies against Cwp84 and generate the lead yeast strains expressing the anti-Cwp84 antibodies. Several
CDI animal models will be employed to assess the efficacy of the lead strains on reducing disease symptoms,
bacterial colonization, spore shedding and preventing disease transmission.
The successful completion of this project will result in a novel probiotic yeast-based immunotherapy that can
effectively prevent the transmission of C. difficile. This project addresses a critical gap in the prevention of C.
difficile transmission. The development of a probiotic yeast-based immunotherapy represents a novel and
potentially transformative strategy that could significantly reduce the incidence of CDI, improve patient
outcomes, and decrease healthcare costs associated with C. difficile infections.

Public health relevance
Narrative Clostridioides difficile is an antibiotic-resistant superbug causing major public health challenges. This project is to develop a novel probiotic yeast-based immunotherapy that can effectively prevent the transmission of the bacterium.